Statistical Methods for Gene Mapping Studies in Admixed Populations

DESCRIPTION (provided by applicant): African Americans and Hispanic Americans represent the two largest racial minority groups in the United States, comprising ~28% of the U.S. population. Both populations are recently admixed and have inherited ancestry from more than one continent. Admixed populations offer a unique opportunity for mapping disease genes that have large allele frequency differences between ancestral populations. Recently, admixture mapping has become one of the main approaches for gene mapping studies in admixed populations. However, admixture mapping has a substantially lower resolution than association analysis. With the increasing availability of large volumes of high-density SNP genotyping data generated in genome-wide association studies (GWAS), the analysis is now moving towards SNP association. However, current available association methods either inflate type I error rates or reduce statistical power when applied to admixed populations. Powerful statistical methods for admixed populations are still underdeveloped. In this application, we will develop powerful statistical methods that are targeted for the analysis of genetic data generated from admixed populations. All proposed aims are motivated by problems that arise in genetics studies on which we are currently working. We have access to 12 large-scale candidate gene and GWAS datasets including 19,135 African Americans and 2,002 Hispanic Americans. These datasets together with the publically available data from the 1000 Genomes Project provide an ideal basis to guide the methodological research in this project. To facilitate gene mapping studies in admixed populations, we propose the following aims: 1) Develop a unified statistical framework for genetic association analysis of unrelated individuals and family data sampled from admixed populations. 2) Develop statistical methods to identify SNPs that can explain an admixture mapping signal. 3) Develop statistical methods for association analysis of copy number variations in admixed populations. 4) Develop statistical methods for analysis of secondary phenotypes in a case-control GWAS in admixed populations. 5) Develop, distribute and support freely available software packages for methods proposed in this application. The methods will be evaluated through analytical approaches, computer simulations and applications to multiple real datasets. PUBLIC HEALTH RELEVANCE: African Americans and Hispanic Americans represent the two largest racial minority groups in the U.S., comprising ~28% of the U.S. population. However, current genome-wide association studies (GWAS), an approach that scans markers across the whole genome to find disease susceptibility genes, has been primarily focused on European Americans. Methods for the analysis of admixed populations such as African Americans and Hispanic Americans are underdeveloped due to the complexities posed by population admixture. In this application, we will develop a suite of statistical and computational tools that are targeted for the analysis of genetic data generated from admixed populations.

Public health relevance
Public Health Relevance African Americans and Hispanic Americans represent the two largest racial minority groups in the U.S., comprising ~28% of the U.S. population. However, current genome-wide association studies (GWAS), an approach that scans markers across the whole genome to find disease susceptibility genes, has been primarily focused on European Americans. Methods for the analysis of admixed populations such as African Americans and Hispanic Americans are underdeveloped due to the complexities posed by population admixture. In this application, we will develop a suite of statistical and computational tools that are targeted for the analysis of genetic data generated from admixed populations.